SV2A PET in Spinal Cord Injury Imaging

ABSTRACT
Traumatic spinal cord injuries (SCI) involve serious neural damage events that can lead to long-term motor and
sensory deficits, as well as cognitive and emotional dysfunctions. Computed tomography (CT) and magnetic
resonance imaging (MRI) are routinely used in the clinical management of SCI. However, neither method
provides physiological information of SCI progression and recovery. We propose to fill this gap by applying
quantitative PET imaging using our newly developed synaptic vesicle glycoprotein 2A (SV2A) radiotracer to track
the synaptic density changes and neuroplasticity over the disease course. Quantitative SV2A PET imaging has
been used to reveal the synaptic density changes in a variety of neuropsychiatric disorders, including Alzheimer’s
disease, Parkinson’s disease, depression, epilepsy, schizophrenia, and stroke. Our pilot PET imaging studies
using the recently developed SV2A PET imaging agents indicate that SV2A PET could be used to quantify
synapse density in the spinal cord of rodents, monkeys, and human. Our pilot SV2A PET rodent imaging study
proved the feasibility of using SV2A PET to detect subtle synaptic loss at 10 days post moderate thoracic
contusion injury. Based on these preliminary results and literature evidence, we hypothesize that altered SV2A
level is a biomarker for neuroplasticity in SCI and SV2A PET can be used to facilitate the diagnose and prognosis
of SCI and to evaluate therapeutic effects in clinical trials. We propose to test the hypotheses through the
following aims: 1) to determine the expression levels and dynamics of synaptic markers in rodent model of SCI
over time, using molecular biology and quantitative in vitro imaging approach; 2) to validate SV2A PET imaging
in the SCI rodent model through small animal PET, ex vivo and in vitro assays and behavioral tests and to apply
SV2A PET imaging in the objective evaluation of therapeutic effects of an anti-Nogo antibody treatment; 3) as a
key step for clinical translation and validation, we will select the most promising SV2A PET tracer for spinal cord
imaging using nonhuman primate as the animal model. Successful completion of this project will yield a sensitive,
reliable, and quantitative imaging method ready to be tested in SCI patients as a diagnosis and prognosis
modality, as well as a research tool to probe the neuroplasticity in SCI animal models and patients. It will also
allow for the objective and longitudinal tracking of SCI progression and recovery.

Public health relevance
PUBLIC HEALTH RELEVANCE: Current diagnosis of spinal cord injury (SCI) mainly relies on X-ray, CT, and MRI, and lacks a quantitative method to evaluate the disease severity and to predict the disease projection. This project is to develop a sensitive, reliable, and quantitative PET imaging method for the diagnosis and prognosis of SCI. It will also allow for the noninvasive longitudinal tracking of SCI recovery and progression and guiding the choice of the therapeutics and the assessment of the effects in clinical trials of disease-modifying interventions.